Hazardous Materials Worker Health and Safety Training (U45), Cooperative Agreement

Program Summary/Abstract:
This is a proposal for a Northeast Hazmat Disaster Preparedness Training Program to be implemented by the
New England Consortium-Civil Service Employees Association (TNEC-CSEA), a partnership between the
University of Massachusetts Lowell (UML), the Massachusetts Coalition for Occupational Safety and Health
(MassCOSH) and CSEA, Local 1000 AFSCME, in New York. Since 1987, TNEC-CSEA has trained 85,866
workers in 4,996 courses, for a total of 704,912 contact hours with NIEHS grant support. TNEC-CSEA will train
workers exposed to hazardous materials; responding to disasters and post-event cleanups and/or rebuilding
efforts, such as public sector workers, private sector day care providers and at-risk workers, such as Latino and
Brazilian immigrant laborers and young workers through high quality training based on evidence-based
science and best practices in worker health and safety (H&S) and adult education. It draws on its strength as a
consortium of a university, a non-profit worker advocacy organization, and a large union of public sector
workers to network and build relationships with a multitude of government, university, business and non-
profit stakeholders. TNEC-CSEA uses proven adult education methods that are hands-on, small-group,
learner-centered, and worker empowerment oriented to maximize its impact on workplace H&S. TNEC-CSEA
will train 1,796 workers annually in HDPTP projects in New England (NE) and New York State (NYS). Its target
population include approximately 120,000 public sector skilled response personnel and 12,000 private sector
Independent Day Care Providers in NYS and underserved immigrant workers and community-based non-
profits and municipalities that serve them, job training, worker centers and tribal entities in NE. TNEC-CSEA
seeks to expand and strengthen its program through new innovations in blended learning, disaster
preparedness, climate change and chemical safety, and expanded delivery of training to vulnerable and
underserved populations and those most at risk for injury. Continued TNEC-CSEA training will prevent
injuries, illnesses and fatalities in thousands of workplaces by linking the best available science for worker
protection with stakeholders in its network of safety and governmental professionals, unions, public health and
environmental justice organizations, worker and job training centers, and tribal entities. It will use its advisory
boards and highly skilled staff, experienced in adult education and worker H&S, to translate knowledge about a
broad range of H&S problems – from hazardous materials to opioids to climate change and disasters.
Protective and preventive interventions are put into practice, and trainings are conducted in Spanish. The
Consortium will do this through direct training of workers and trainers, supporting the worker H&S
movement, and linking stakeholders together in creative and fundamental ways.